Neural control of coordinated eye movements

Project Summary / Abstract
We look between targets located in the 3D visual environment by making disjunctive saccades that bring
the target image onto both foveae. Each gaze shift is followed by a fixation period for visual analysis during which
the new vergence level must be maintained. Most studies have focused on the circuitry controlling conjugate
saccades, whereas the neural control of disjunctive saccades and vergence eye movements has received less
study. Several models suggest that abducens motoneurons send a monocular command carrying information to
each eye to control disjunctive saccades. Other models have proposed the existence of saccade-vergence burst
neurons (SVBNs) that project to medial rectus motoneurons and are active only during disjunctive saccades. We
have identified this novel cell type, which only discharge during disjunctive saccades, in the central
mesencephalic reticular formation (cMRF) lateral to the oculomotor nucleus (OMN). Electrical microstimulation
in this region of the cMRF elicits disjunctive saccades, whereas inactivation impairs vergence gaze holding.
Recent anatomical findings have demonstrated that premotor neurons related to the near response are located
in the cMRF, and that they project to the supraoculomotor area (SOA) and to the OMN. We hypothesize that the
cMRF, and the SVBNs in particular, play a critical role in the generation of disjunctive saccades. We further
hypothesize that projections between the cMRF and SOA form part of a previously undescribed neural circuit
that produces vergence integration, allowing vergence angle to be maintained during fixation. Other anatomical
and electrophysiological findings demonstrate that the cerebellum, specifically, the caudal fastigial nucleus and
the posterior interposed nucleus, play a role in controlling vergence eye movements in both normal and
strabismic individuals. We therefore hypothesize that the cerebellar input to the cMRF/SOA complex helps
encode or modulate disjunctive saccades. Guided by these overarching hypotheses, we propose Specific Aims
to characterize this neural circuitry. 1. To determine the role of SVBNs and the cMRF in the production of
disjunctive saccades; 2. To test the hypothesis that the cMRF/SOA complex is the vergence integrator
responsible for maintaining the level of convergence; 3. To determine how the cerebellar projections to
the cMRF/SOA circuitry are involved in the generation of disjunctive saccades and vergence eye
movements. To test our specific hypotheses, we will use established neurophysiological techniques
(electrophysiological recordings, antidromic activation, electrical microstimulation and reversible
pharmacological modulation). The overall goal of our project is to substantially increase our understanding of the
neural circuitry controlling 3D eye movements in primates, and to broadly impact the oculomotor field, leading to
new neurophysiological and modeling approaches. These findings will also provide a critical basis for
understanding the absence of precise binocular coordination in eye movement dysfunctions such as strabismus.

Public health relevance
Project Narrative Moving our eyes between targets located at different distances from us requires disjunctive saccades and holding our eyes on each target requires the integration of vergence signals to produce a maintained vergence angle. Individuals with strabismus do not coordinate their eyes sufficiently to fixate targets in this way, but little is known about the neural control of disjunctive saccades and vergence integration in normal subjects. Our proposed studies aim to understand the role of the interconnected neural circuitry in the central mesencephalic reticular formation, supraoculomotor area and cerebellum that allows individuals to make disjunctive saccades and maintain vergence angle as they view targets in three-dimensional space.